CommunityRx-Dementia

PROJECT SUMMARY/ABSTRACT
Two thirds of people with dementia and their caregivers are women. Studies have focused predominantly on
white dementia caregivers, consistently showing higher rates of burden among women caregivers compared
with men. Although women caregivers often rely on men (brothers, husbands, fathers) for support for themselves
and their loved one living with dementia, little is known about how these relationships work, especially in African
American/Black (AA/B) families. The CommunityRx-Dementia (CRx-D) intervention supports caregivers of
people with dementia using evidence-based algorithms to systematically match people to nearby community
resources for wellness, self-care and caregiving. The active parent award R01AG064949 supports a single-blind
randomized controlled clinical trial to: (1) Among caregivers with unmet health-related social needs, evaluate the
effects of CRx-D versus usual care on caregiver self-efficacy and secondary psychosocial and behavioral
outcomes, as well as health and healthcare utilization; (2) Evaluate acceptability of the intervention and the
effects of CRx-D versus usual care on the health care experience and likelihood of sharing community resource
information with others; and (3) Qualitatively assess caregivers' experiences with the CRx-D intervention; the
role of stigma in disclosing needs and accessing resources; and experiences sharing resource information with
others. Within the scope and to increase the impact of the parent award, the proposed supplemental research
will address three specific aims: (1) Examine gender differences among AA/B caregivers, especially in timely
and under-studied domains targeted by the CRx-D trial, including caregiving self-efficacy, knowledge and use of
community resources and how these factors relate to important health conditions including caregiving burden,
depression and stress; (2) Assess gender differences in experiences with the CRx-D intervention, the role of
stigma in disclosing needs and accessing resources, and experiences sharing resource information with others;
and (3) Assess caregiver support networks, particularly the effects on women caregivers of caregiving support
provided and procured by male family and friends, gender differences in caregiver coping mechanisms, and
familial gender roles related to caregiving. This study will expand our data collection activities within the
framework of the original trial to examine gender roles influencing caregiver responsibilities and well-being in a
predominantly AA/B population of dementia caregivers. Insights generated by this work will be used to increase
the overall impact of the parent project, fill major knowledge gaps about gender differences among dementia
caregivers, and inform future intervention design and delivery. This proposal addresses Objective 1.3 of the
Trans-NIH Strategic Plan for Women's Health Research by evaluating the effects of caregiving exposure on
women's health and well-being using a community-engaged approach.

Public health relevance
PROJECT NARRATIVE The ongoing CommunityRx-Dementia (CRx-D) trial addresses a federal call for community resource linkage interventions to support more than 16 million caregivers of the growing U.S. population of persons with Alzheimer's disease and related dementias living at home. Within the scope and to increase the impact of the CRx-D trial parent award, the proposed supplemental research responds to a call from the Office of Research on Women's Health and the National Institute on Aging (NOT-OD-22-030) to examine gender roles influencing caregiver responsibilities and well-being in a predominantly African American/Black population. This proposal addresses Objective 1.3 of the Trans-NIH Strategic Plan for Women's Health Research by evaluating the effects of caregiving exposure on women's health and well-being using a community-engaged approach.